Training in Comparative Lung Biology and Medicine

PROJECT SUMMARY
The UC Davis NHLBI-funded T32 in Comparative Lung Biology and Medicine prepares predoctoral and
postdoctoral trainees during a critical and formative period in their research careers. The program is an
institutional resource providing structured training pathways that align with the needs of individual trainees while
addressing the need to grow a lung biology and translational science workforce. The program will be led by
multiple PIs Dr. Nicholas Kenyon and Dr. Elena Goncharova, who will bring their complementary expertise in
research and mentoring to this T32 program. The program includes six predoctoral (six graduate students) and
three postdoctoral scholar (MD, DVM, RN/PhD, and PhD) positions. Diverse trainees are selected through a
highly competitive application process drawing applicants from the Schools of Medicine and Veterinary Medicine,
the College of Biological Sciences, and the College of Engineering. This program has trained more than 125
scholars in lung biology and medicine over the last 44 years, and is newly invigorated by an infusion of more
than 10 funded, diverse junior faculty and an enhanced curricular focus on oral and written science
communication and research career skills. This pre- and post-doctoral T32 program aims to train the next
generation of scientists through interdisciplinary research and coursework that address issues of direct relevance
to the NHLBI mission. Faculty preceptors will direct research training in three primary areas: 1) Lung Biology,
Immunology and Molecular Medicine; 2) Environmental Lung Health and Engineering; and 3) Data Sciences and
Translational Research in Pulmonary and Critical Care Medicine. The T32 provides a creative training and
scientific milieu facilitating career development for trainees as independent investigators in academic, industry,
or government research careers, and as members of high-level translational science teams.

Public health relevance
PROJECT NARRATIVE The UC Davis T32 in Comparative Lung Biology and Medicine prepares predoctoral and postdoctoral trainees during a critical and formative period in their research careers. The program aims to train the next generation of scientists through interdisciplinary research and coursework that address issues of direct relevance to the NHLBI mission. Our faculty and trainees foster a creative training and scientific milieu that facilitates their development into independent investigators in academic and government research careers.